Miniaturized head-mounted device for pan-cortical electro-optical activity monitoring

PROJECT SUMMARY
This application is submitted in response to the Bioengineering Research Grant’s R01 mechanism. This
application proposes to develop a miniaturized head-mounted device that seamlessly integrate wide-field
optical imaging and electrocorticogram (ECoG) recordings to achieve multimodal activity mapping of the whole
cortex during free behavior. The proposal builds on technological developments in our lab – transparent
polymer skulls that provide optical access to an estimated 800,000 to 1,000,000 neurons across 90 mm2 of the
surface of the dorsal cortex of the mouse. In AIM 1 we will develop head-mounted imaging systems for
mesoscale activity mapping of the whole dorsal cortex in freely moving and behaving mice. In AIM 2, we will
engineer transparent polymer skulls integrated with multilayer inkjet-printed electrocorticogram (ECoG)
electrode arrays that allows simultaneous optical imaging and cortical surface field potential recordings. We will
engineer custom interface electronics integrated into the head-mounted device developed in AIM 1 to enable
simultaneous ECoG recordings and cortex wide imaging in freely moving mice. In AIM 3 we will utilize the
devices developed in Aims 1 and 2, to study dynamics of cortical activity patterns during novel object
recognition and exploration tasks. These developments will enable fundamentally new kinds of experimental
studies in the mouse and reveal new insights into the neuronal computations that underlie sensory perception,
action and cognitive processes.

Public health relevance
PROJECT NARRATIVE This proposal develops miniaturized head-mounted devices for simultaneous electrical and optical activity mapping of the whole dorsal cortex in behaving mice. These developments will lead to fundamentally new experimental paradigms in mice and enable new insights into the neuronal computations that underlie sensory perception, action and cognitive processes.